KSHV-mediated metabolic reprogramming for LANA expression and viral persistency

Project Summary/Abstract
Metabolic reprograming has been readily recognized as the hallmark of cancer. Specifically, three-
dimensional (3D) cell system is well documented to regain intrinsic metabolic properties and to better
mimic the in vivo situation than two-dimensional (2D) cell system. We have shown that Kaposi’s
sarcoma-associated herpesvirus (KSHV), an etiological agent of Kaposi’s sarcoma (KS) and pleural
effusion lymphoma, specifically alters host spermidine and proline syntheses in a 3D-dependent
manner, contributing to the LANA-mediated latent episomal maintenance for viral persistency and
oncogenesis, which is a crux of this application. As this KSHV-mediated spermidine and proline
biosynthesis reprograming is also shared by most non-viral cancers, this study will contribute to
understanding general cancer metabolic reprograming.

Public health relevance
Project Narrative This application will investigate how KSHV deregulates host spermidine and proline metabolic pathways for LANA expression and whether the spermidine and proline metabolic pathways are therapeutic targets for KSHV persistency and oncogenesis.